African Breast Cancer - Disparities in Outcomes - Plus (ABC-DO Plus)

Project Summary
Breast cancer is the most common type of cancer diagnosed and the second cause of
cancer death in sub-Saharan African women. The few studies on breast cancer survival in this
region reported low short-term survival rates, but none were able to comprehensively address
reasons for low survival, how to improve survival, nor assess five-year and longer-term survival
and survivorship. Further, the impact of more aggressive molecular subtypes, common in women
of African-descent, on breast cancer survival in sub-Saharan Africa has not yet been investigated.
The African Breast Cancer-Disparities in Outcomes (ABC-DO) study is a five-country
sub-Saharan African breast cancer cohort initiated in 2014. During 3 years of recruitment, over
2100 women were recruited in Uganda, Nigeria, Zambia, Namibia, and South Africa. In the
proposed project, ABC-DO-Plus, we will build on ABC-DO – namely the established
collaborations, research staff, tumor collections, ethical and legal permissions; and novel and
successful mobile-Health (mHealth)-implemented follow-up – to actively follow-up women for a
further 2 years to 5 years post-diagnosis, examine for the first time 5-year survival overall and by
key prognostic factors, molecular subtypes, treatment availability, affordability and compliance,
socioeconomic determinants and comorbidities present in this setting, particularly high BMI and
HIV.
Breast cancer survivorship research, i.e. the health of women with breast cancer post-
treatment, has largely been neglected in sub-Saharan Africa. ABC-DO-Plus will examine, for the
first time, longitudinal changes in health-related quality of life up to 5 years after a woman’s breast
cancer diagnosis.
ABC-DO-Plus will inform interventions needed to mitigate the excessive number of deaths
of women with the disease, and improve the quality-of-life of survivors. Utilizing a within-African
framework of five countries with different cancer care politics, but also representing individual
socioeconomic and cultural diversity, will enable comparisons across settings and hereby
identification of modifiable factors influencing BC survival.
Furthermore, its findings on the proportions of more aggressive tumor molecular subtypes,
and how these may affect survival, as well as on the impact on survival of comorbidities such as
HIV, will be of relevance to other black women in the US and elsewhere.
The success of the proposed ABC-DO-Plus, and its manifold goals, will be ensured
through continuity of the experience of the previous 4+ years’ ABC-DO fieldwork, its established
research infrastructure, and the efficient mHealth follow-up approach of this unique cohort.

Public health relevance
Project narrative In sub-Saharan Africa, short-term breast cancer survival rates are relatively low, but five-year and longer-term survival and survivorship have not been comprehensively studied. In the African Breast Cancer-Disparities in Outcomes (ABC-DO) study, a five-country sub-Saharan African prospective study of over 2100 women with breast cancer, we have confirmed unacceptably low survival rates compared to those in high-income countries, however we have also found that survival rates differs between settings, and in the first 2 years after diagnosis, outcomes are much more favorable in the growing number of women being diagnosed at earlier stages. We now propose to extend ABC-DO to examine, for the first time in sub-Saharan Africa, five-year survival and its socioeconomic, clinical and biological determinants, as well as longitudinal changes in health related quality of life.